Glycan Structure Archive (GSA) prototype in support of GlyGen's data integration - Yr 5 Admin Supp

ABSTRACT Recent years have highlighted the significant impact of glycans in biomedical research especially in aspects of immunology, role in biological functions, impact in diseases, and more. Technical advancements in recent years have allowed researchers to perform glycomics and glycoproteomics analysis more accurately and efficiently, resulting in rapid growth of the volume of data in the literature and a great need for robust evidence-based archival glycan record maintenance. This need can be at least partially met by a repository that allows authors to submit and update data while database developers provide mechanisms for data archiving without any editing. We propose to develop a prototype glycan archive (a primary database) to store registered glycan structures and allow users to deposit new glycans which will be shared with existing resources. It is expected that this effort will lead to the development of an internationally managed glycan archive collaboration, parallel in concept to the International Nucleotide Sequence Database Collaboration (INSDC) that harmonizes and maintains databases like GenBank, DDBJ, ENA for nucleotides. The glycan archive prototype will be developed by GlyGen under subdomain gsa.glygen.org. and it will house all glycans sourced from existing public databases like GlyTouCan, PubChem, ChEBI, KEGG glycan, and others. Robust QC procedures will enhance the value of the submitted records and all glycan records will be associated with an unique ID that will be cross-referenced to other databases. Novel informatic-based structural validation will flag submissions that contain unexpected features, allowing additional evaluation before or after incorporation into the archive or secondary databases. We anticipate that the proposed mechanism will be highly valuable for researchers, data curators, bioinformatics databases, and also provide a historical record of when a particular glycan was published.

Public health relevance
NARRATIVE This supplement is designed to facilitate the development of a prototype archival repository for glycans which will allow users to register new glycan structures with on-the-fly feedback provided to submitters based on codified rules derived from expert-knowledge. The glycans housed by the archive will be shared and synched routinely with existing glycan and chemical repositories in the United States and internationally.